Signal Transduction to P70 S6 Kinase 1

Summary
A continuous challenge for both single cells and multicellular organisms is that the availability of nutrients is
fluctuating constantly. This is particularly the case for cancer cells in solid tumors or exposed to different stromal
environments. Hence, cells must be able to sense the amount of nutrients in the environment to coordinate
energy-consuming anabolic reactions with energy-producing catabolic reactions. This task is largely carried out
by mTOR complex 1 (mTORC1), a protein kinase complex that senses various environmental cues and
coordinates anabolic and catabolic processes to regulate cellular homeostasis. mTORC1 becomes activated
when amino acids, energy sources, oxygen and growth factor levels are sufficient. Under these conditions
mTORC1 promotes cell growth by boosting protein synthesis, lipid synthesis and nucleotide synthesis. However,
whereas many of the key players involved in growth factor signaling to mTORC1 have been characterized, gaps
remain in our understanding of how mTORC1 senses amino acids. It is also unclear how different cancer cell-
associated mutations provide tumor cells with the ability to optimize usage of these regulatory components or
find ways to overcome deficiencies in these mTORC1 regulators. Additionally, once activated it is still a mystery
how mTORC1 regulates and coordinates the many processes required to promote cell growth, proliferation,
migration, and survival, and how the altered signaling in cancer cells leads to resistance to current mTORC1
therapies with the allosteric inhibitor, rapamycin (an FDA approved mTORC1 inhibitor) and catalytic inhibitors.
Furthermore, it remains unclear how mTORC1-S6K1 can regulate the variety of biological processes associated
with cancer biology. To better understand mTORC1 signaling, we can now combine our mTORC1 RNAi screens,
and phosphoproteome, interactome, metabolome and gene expression data sets, to support our efforts. In this
proposal we have outlined several goals based on these data sets, our published work and the extensive
experience of my lab, that support our long-term goals of defining mTORC1-S6K1 regulation and signaling,
and for revealing new information to support efforts to kill cancer cells with activated mTORC1 signaling. Our
discoveries and experience have now led us to investigate a novel mechanism for responding to amino acid
deficiency (aim 1), a new pathway for regulating nuclear events linked to biological processes hijacked by cancer
cells (aim 2), a novel S6K1 effector kinase, its role in mRNA biogenesis and new downstream processes (aim
3) and a new link between mTORC1-S6K1 and mRNA methylation. In conclusion, there’s a critical need for a
greater understanding of the molecular basis of mTORC1 regulation and signaling, as well as its links to
processes associated with cell growth, metabolism, survival and drug resistance. Our expectations are that
successful completion of the proposed work will impact cancer biology/physiology and therapy through the
identification of new therapeutic targets and biomarkers that can lead to the improve detection and elimination
of cancer cells with unregulated mTORC1 signaling, estimated to occur in 70-80% of all human cancers.

Public health relevance
Project Narrative / Relevance: We have generated a vast amount of transcriptomic, metabolomic and proteomic/phosphoproteomic data focused on mTORC1 and S6K1 signaling with the goal of providing us with a unique tool box with which to define how mTORC1 regulates gene expression, mRNA processing, translation and metabolism and their contribution to cell growth and carcinogenesis. These data and our subsequent research revealed new links to: (i) the regulation of lysosome trafficking and signaling through the activation of GTPases Rap1a/b upon amino acid insufficiency, (ii) a new mode of regulation of GSK3 and its links to nuclear signaling events by mTORC1, (iii) a new link between mTORC1-S6K1 and the regulation of SRPK2, a novel kinase effector of mRNA expression, processing and critical processes associated with cancer cell growth and survival, and (iv) the discovery of mTORC1-S6K1 regulation of RNA methyl transferases and epitranscriptomics. With the described aims, we have placed ourselves in the unique position to fully uncover and understand at a biochemical and molecular level new regulatory processes, new biomarkers and new potential targets for drug discovery, that are needed for personalized therapeutic intervention in cancer and many metabolic diseases associated with improper mTORC1 signaling such as diabetes, obesity, aging and neurodegeneration.